Center for Environmental Health in Northern Manhattan

Project Summary of the Overall Component
Bolstered by new leadership and external recruitment of multiple new senior and junior faculties, the NIEHS
Center for Environmental Health in Northern Manhattan (CEHNM) brings together a highly inter-disciplinary
cadre of 33 full and 8 associate members (35% physician scientists) from 14 Departments at the Mailman
School of Public Health, the College of Physicians & Surgeons, and the Lamont Doherty Earth Observatory of
Columbia University. CEHNM’s members concentrate their efforts in four themes, which we will advance
through corresponding working groups (WGs): Environmental Epidemiology (WG1), Environmental Epigenetics
and Disease Mechanisms (WG2), and Climate and Health (WG3), which all feed into a Translation & Disease
Prevention WG (WG4). CEHNM has a strong translational focus, leading an especially large number of
remediation studies and environmental intervention trials (24 ongoing or recently completed) that effectively
translate our research into improved public health. Our WG organization reflects these strengths.
CEHNM supports three Facility Cores (FCs): (i) the Integrative Health Sciences FC (IHSFC) is the port of entry
and coordination to all Center services; it also assists members with collecting, processing, and managing
biological specimens, and provides leading-edge biological, molecular, and –omic lab analyses; (ii) the
Exposure Assessment FC creates tailored solutions for exposure assessment (e.g., customized air monitoring
equipment) and provides state-of-the-art analyses of environmental samples (air, dusts, water, soil); it also
complements IHSFC’s biological services with bioaerosol and trace organics analyses; (iii) the Study Design
and Data Analytics FC assists with design consultation, data management, biostatistics, bioinformatics/omics
data, and public access data.
CEHNM’s Pilot Project Program has a 6-week turnaround from submission to funding and has yielded 28-fold
dollar-per-dollar NIH funding returns; in the current cycle, all awards were received by PIs who were either
junior and/or non-members before the award. In the current cycle, our Career Development Program has
provided funding support to six junior faculty and has advanced junior and senior investigators toward
interdisciplinary research careers in environmental health sciences; in the next cycle, we will provide
$35,000/yr for two years to six additional junior faculty members. Finally, our Community Engagement Core,
which focuses on healthy and resilient homes and communities, has addressed a wide array of critical issues,
including facilitating conversion to clean heating, reducing local vehicular emissions, climate resilience, and
emergency preparedness among vulnerable groups. Locally, we serve the highly diverse (Hispanic or African
American) communities of Northern Manhattan and the South Bronx, a population with up to 43% of residents
who live in poverty and disproportionally burdened by environmental determinants of poor health.

Public health relevance
PUBLIC HEALTH IMPACT (Overall Component) The goal of the NIEHS Center for Environmental Health in Northern Manhattan (CEHNM) is to provide essential support for the development of critical and novel research into the environmental causes of poor health through pilot projects, a career development program, multidisciplinary research working groups, and facility cores. The CEHNM has been very successful in achieving this goal by advancing member’s capacity to obtain research funding, attracting new investigators to the center and helping members establish themselves as leaders in environmental health science and public health. For this competitive renewal, we propose a new organization of our research themes, novel directions for future activities, new augmented services, advanced community engagement activities, and renewed leadership to ensure that CEHNM will continue to respond to the most urgent local and global public health needs of our times.